Enhanced Pain Coping in Cancer (EPIC)

PROJECT SUMMARY/ABSTRACT
Chronic pain is a common symptom that affects 30-40% of cancer survivors, diminishing their quality of life,
impairing physical functions, and increasing health care costs. Breast cancer survivors constitute the largest
group of survivors with more than 4.1 million in the US. Nearly one in two breast cancer survivors who take a
class of medication known as aromatase inhibitors are affected by a chronic painful condition, aromatase
inhibitor-associated arthralgia (AIA). AIA is associated with reduced physical activity, increased risk of falls, and
reduced AI adherence, leading to increased overall mortality. With insufficient relief from conventional
treatments and a rapidly growing population of breast cancer survivors, there is an urgent need to develop
novel, effective, and scalable pain management options. Mindfulness-Oriented Recovery Enhancement
(MORE) is an innovative mindfulness-based intervention (MBI) rooted in affective neuroscience that integrates
training in mindfulness, reappraisal, and savoring skills to specifically target chronic pain and related symptoms
(e.g. psychological distress). Although the efficacy of MORE for pain in non-cancer populations has been
established, the potential for this mindfulness intervention to address pain and comorbid symptoms in breast
cancer survivors has yet to be confirmed. Therefore, a rigorous, adequately-powered randomized controlled
trial is needed to conclusively determine whether MBIs such as MORE can alleviate AIA. To address this
critical gap in research and clinical care, we have convened a multidisciplinary team to conduct the Enhanced
Pain Coping in Cancer (EPIC) trial with the following specific aims: 1) to evaluate the specific efficacy of MORE
for managing AIA among breast cancer survivors, 2) to evaluate the specific effects of MORE on comorbid
symptoms, quality of life, and adherence to AIs, and 3) to elucidate the cognitive-affective mechanisms of
MORE for pain management among breast cancer survivors. The MORE intervention that we will test aligns
with a downward spiral of chronic pain model and neuroscience and is based on discoveries from preliminary
studies. For this multisite, randomized controlled trial we will randomize 200 breast cancer survivors free of
oncologic disease with AIA to one of two eight-week treatments: 1) MORE or 2) supportive group
psychotherapy (SG). We will assess the primary outcome (pain-related functional interference) and secondary
outcomes at baseline, week 8 (end of treatment), week 12 and week 24 (primary end point) using validated
patient-reported outcomes. EPIC will address major methodological limitations of existing MBI trials including
pain not being a primary outcome, no eligibility requirement for having pain, and the MBIs under investigation
having been developed to target stress management rather than pain management. EPIC will provide timely
clinical evidence for MORE, a neuroscience-informed, mindfulness-based intervention for pain and co-morbid
symptoms, during cancer survivorship. Further, virtual delivery will ensure MORE is highly scalable with broad
reach to improve pain management for millions of breast cancer survivors across the US.

Public health relevance
PROJECT NARRATIVE Chronic pain induced by aromatase inhibitor therapy is a common and debilitating symptom impacting breast cancer survivors. The Enhanced Pain Coping in Cancer (EPIC) trial investigates a novel, scalable, neuroscience-based, non-pharmacological virtual intervention with potential to change the paradigm of pain clinical care for millions of breast cancer survivors with aromatase inhibitor-associated arthralgia.